An Observational Study of Cardiac Critical Care Management in Multidisciplinary and Cardiac Intensive Care Units

During the past half century, the coronary care unit has evolved from a site for post myocardial infarction care and primary detection and treatment of arrhythmias to its current form as a cardiac intensive care unit (CICU). The contemporary CICU provides care for an increasingly aging and complex patient population. The clinical environment of the modern CICU encompasses critical non-cardiac co-morbid conditions and multi system organ dysfunction associated with advanced cardiac conditions ranging from refractory heart failure, ischemia, and dysrhythmias through cardiogenic shock and even septic shock in immunosuppressed heart transplant patients.

The protocol related to this project is a multicenter study that was approved by the National Heart Lung and Blood Institutional Review Board in May 2018. The study is sponsored by the Academic Executive and Steering Committees of the Critical Care Cardiology Trials Network (CCCTN) and coordinated by The TIMI Study Group at Brigham and Women's Hospital, Harvard Medical School, Boston, MA.

At the NIH Clinical Center (CC), data collection has captured information from records of adult patients with cardiac conditions admitted to the multidisciplinary ICU during a 2 month "snap-shot" period. The study involves only a review of patient records and will not use specimens or involve participant contact. Medical records were reviewed from participants enrolled in NIH protocols related to their underlying disease(s).

This study will not involve any interventions or changes to the patients care. The study involves collection and analysis of information obtained as part of routine clinical care as documented in the medical record. Data will be collected for eligible subjects admitted to the Clinical Center after the protocol approval date. Only de-identified data will be submitted to the Data Coordinating Center. The information resulting from inclusion in this study will not have any health or medical implications for subjects and privacy standards will be observed rigorously.

Over the life of the protocol (as of August 2025) a total of 64 NIH CC ICU patient records have been entered into the CCCTN registry which contains information on over 43,500 ICU admissions of which about 6,000 were obtained during the 2024-2025 reporting period.